The role of pyruvate oxidase in nitrosative stress resistance by Streptococcus parasanguinis

PROJECT SUMMARY
Streptococcus parasanguinis is an oral commensal bacterium that produces hydrogen peroxide through
pyruvate oxidase (PoxL) activity. This hydrogen peroxide can react with nitrite (NO2) to form peroxynitrite
(ONOO-) and other reactive nitrosative species (RNS) that are potent antimicrobials. Previous work in our lab
has demonstrated that S. parasanguinis-mediated RNS production can inhibit growth of pathogens such as
Streptococcus mutans and Pseudomonas aeruginosa. Despite the antimicrobial effects of RNS on a variety of
bacteria, S. parasanguinis is uniquely resistant, with S. parasanguinis having a growth advantage in the
presence of NO2 and ONOO-. Mechanisms of this resistance are unknown. S. parasanguinis does not utilize
catalase to mediate oxidative stress and cannot reduce nitrate or its derivatives. However, previous literature
has shown that in some streptococci, pyruvate oxidase reduces oxidative burden. To determine if PoxL plays a
similar role in the S. parasanguinis nitrosative stress response, a poxL mutant was tested for its role in RNS
resistance. Interestingly, the poxL mutant had impaired biofilm growth that could be partially rescued in the
presence of either NO2 or ONOO-, indicating that NO2 and ONOO- compensate for the loss of poxL-dependent
biofilm formation, and that poxL may modulate sensing or metabolism of nitrogenous intermediates. Further,
the poxL mutant has increased ATP production, indicating that poxL is an important mediator of metabolism.
Metabolomics analysis revealed that in the presence of NO2, S. parasanguinis undergoes a global shift in
many redox scavengers, indicating that the response to RNS and oxidative stress may be coupled. This project
aims to determine the role PoxL has on the RNS response. The overarching hypothesis for this proposal is that
S. parasanguinis coordinates its nitrosative stress response through pyruvate oxidase. Aim 1 serves to
determine the regulation of the RNS stress response by determining 1) if SpxR, which mediates the oxidative
stress response in streptococci, is involved in the nitrosative stress response through PoxL regulation, nitrite
uptake, and metabolism, and 2) if other enzymes that utilize pyruvate as a substrate also mediate the RNS
response. Aim 2 works to understand the regulation and effects of PoxL in vivo by determining 1) if PoxL
mediates colonization in a NO2-dependent manner, and 2) if poxL expression is altered by local nutritional
availability with or without NO2. Taken together, we will use a molecular and systems biology approach,
coupled with infection models to understand the fundamental mechanisms involved in nitrogen metabolism and
the nitrosative stress response in S. parasanguinis. Data generated from this proposal will benefit the oral
microbiology field by understanding a noncanonical approach to nitrosative stress resistance and by
understanding the role nitrogenous intermediates play in the colonization of an oral commensal.

Public health relevance
PROJECT NARRATIVE Streptococcus parasanguinis is an oral commensal bacterium that inhibits both oral and respiratory pathogens through the generation of reactive nitrosative species (RNS). Interestingly, S. parasangunis is uniquely resistant to nitrosative stress and does not possess canonical mediators to assist with its nitrosative stress response. This proposal seeks to understand the role of pyruvate oxidase, a putative mediator of the nitrosative stress response that is required for RNS generation in S. parasanguinis, on the nitrosative stress response, metabolism, and in vivo colonization.